Mass Spectrometry Investigations into the Glycosylated Neuropeptidome in Response to Hypoxic Stress

Project Summary/Abstract
Neuropeptides (NPs), important neuromodulators and signaling molecules, are very diverse in structure
and can have distinct functions altered by location, concentration, and co-modulation with other NPs,
though the functions of many are unknown. Their global characterization is challenging due to their
diversity and low abundance in vivo. Glycosylation is a complex post-translational modification that can
further complicate NP characterization. Defined by the addition of a glycan comprised of various
monosaccharides in different combinations and configurations, peptide and protein glycosylation can
modify binding affinity, trafficking, lifetime, and function. Although glycan characterization is becoming
more common, the functional role of glycosylation on NPs remains sparsely studied and unclear.
Characterization is partially limited by its even lower abundance in vivo compared to non-modified NPs
and thus requires new and effective strategy. This can be performed by mass spectrometry (MS), a
sensitive and selective analytical technique, which is able to identify and localize various glycosylation
modifications of NPs. While not previously studied in the context of NPs, hypoxia exposure has been
shown to lead to dysregulation of glycosylation, both in environmental and tumor contexts. Recently,
NPs have been implicated in stress responses to hypoxic conditions, though modified NPs have not
been examined. The goal of this project is to address this critical knowledge gap and to elucidate the
role of glycosylation on NPs due to exposure to hypoxic stress. This will be performed in the crustacean
model organism due to its simple, well characterized neuroendocrine system and the homology present
between some human NPs. Aim 1 focuses on developing a workflow for the increased detection and
characterization of glycoNPs present in blue crabs, Callinectes sapidus. This will be performed by the
enrichment of the low abundance glycosylated NPs prior to MS analysis, as well as the optimization of
a MS fragmentation method. Aim 2 will implement the developed strategy from Aim 1 to characterize
the hypoxia stress-induced modulation of glycans on NPs both quantitatively and qualitatively, looking
at the relative changes in expression abundance and expressed glycoforms. Aim 3 will lead to the
further elucidation of glycosylation roles and effects by studying structural trends through ion-mobility
spectrometry MS, a technique that can measure structural information through gas-phase mobility
values. Correlation between structural characteristics of glycoNPs versus non-glycosylated NPs can
provide insight into their varying binding affinities and functional roles. Together, these aims will provide
insight into the roles of glycosylation on NPs and how their regulation is modulated by biological coping
mechanisms resulting from a hypoxic environment.

Public health relevance
Project Narrative This project will improve the understanding of glycosylation effects on the roles of neuropeptides in the neuroendocrine system globally, as well as its role in regulating physiological responses to hypoxia exposure through the development and application of mass spectrometry-based quantitative and qualitative approaches. Glycosylated neuropeptides will be identified that are involved in the stress regulation process and structural trends will be examined to elucidate functional effects of signaling molecule glycosylation. The functional and structural knowledge gained will enable the eventual development of glycosylated therapeutics to better treat diseases or medical conditions where hypoxia stress is implicated such as stroke, cardiac arrest, or chronic kidney disease.